2025 Hormone-Dependent Cancers Gordon Research Conference and Gordon Research Seminar

The Gordon Research Conference (GRC) and the associated Gordon Research Seminar (GRS) on “Hormone-Dependent Cancers” build on the success of five prior GRC conferences on this topic in 2013, 2015, 2017, 2019, and 2023. No meeting was held 2021 due to COVID-19 restrictions. The 2025 GRC “Hormone-Dependent Cancers: A Place in Time, from the Global to the Cellular, the Significance of Environment and Tumor Dynamics on Disease Progression” will provide the stimulating and engaging format for interaction and fruitful exchange of knowledge to allow new ideas, collaborations, and projects to develop, with the ultimate goal to decrease suffering and casualties from the disease. We will cover varied perspectives on hormone-dependent cancers through the voices of early stage and experienced investigators, as well as investigators from academia and industry. The GRS entitled “Next-Generation Approaches in Basic Science and Clinical Data Integration” will precede the GRC, and is specifically geared towards early-career scientists (ECS) including graduate students, postdoctoral fellows, and clinical fellows.
Leading national and international speakers will present research that represents the entire spectrum, from basic biology to clinical application of their biological findings. The focus of the meeting is hormone-dependent cancers, with an emphasis on breast and prostate cancers, since 75% of all breast cancers and all prostate cancers are deemed hormone-dependent. The presentations will be divided among a total of 9 sessions: Keynote Session 1: Advances in Therapeutic Targeting; Session 2: Breast and Prostate Metastasis; Session 3 How Important is Location?; Session 4: Nuclear Receptors, Steroid Sisters, and Orphan Brothers; Session 5: Dynamic Actions, Epi-Genomic and Epi-Transcriptomic Plasticity with Disease Progression; Session 6: Immunology, Metabolism, and Next Generation Approaches to Targeted Treatment Strategies; Session 7: Hormone-Dependent Cancer Global and Population Outcomes; Session 8: Artificial Intelligence (AI), revolutionizing translational research; Keynote Session 2: Key Areas and Questions in Hormones & Cancer.
The overall goal of the 2025 GRC/GRS is to encourage the stimulation of new projects and scientific collaborations across multiple disciplines and through informal means. With the discussion of state-of-the-art research and industry perspectives on hormone-dependent cancers, we hope to foster new discoveries, create improved therapies targeting these cancers and ultimately, improve patient outcomes.

Public health relevance
The 2025 Gordon Research Conference (GRC) on “Hormone-Dependent Cancers: A Place in Time, from the Global to the Cellular, the Significance of Environment and Tumor Dynamics on Disease Progression” and the accompanying Gordon Research Seminar (GRS) “Next-Generation Approaches in Basic Science and Clinical Data Integration” will provide a premier forum for discussing cutting-edge approaches to understanding the role of the tumor microenvironment in the heterogeneity and progression of hormone-dependent cancers. The 2025 GRC/GRS will feature presentations from early-stage and experienced investigators, including those from academia and industry. It aims to challenge current perspectives on hormone-dependent cancers and address the essential, yet unanswered, big questions in the field.